Emerging imaging technologies for automated analyses of calcineurin-dependent brain function

Project Summary
Calcineurin is a phosphatase with broad clinical significance. Calcineurin inhibitors are used as
immunosuppressants to prevent rejection of organ transplants and calcineurin signaling is thought to play a
critical role in Down syndrome and Alzheimer’s disease. However, very little is known about the effects of
modulated calcineurin signaling in the brain. Animal model systems are available, but changes in neural
networks are easily missed when studying an organ as complex as the brain. Analyses of behavior offer a
potential solution, since subtle changes in brain structure and function can be detected. The laboratory of the
principal investigator developed an imaging system for automated analyses of behavior in zebrafish larvae.
This imaging system can measure larval responses to moving visual stimuli in microplates, which is not
possible with commercially-available imaging systems. The capabilities of this imaging system will be further
expanded for automated analyses of complex behaviors in a 384-well format. The project is guided by the
central hypothesis that novel imaging technologies for high-throughput analyses of vertebrate behavior will
contribute to the discovery of novel treatments for neural dysfunction. This hypothesis will be tested in three
specific aims. The first aim is to optimize imaging technologies for high-throughput analyses of complex
behavior. The second aim is to use the optimized technologies to image calcineurin-dependent behaviors.
The third aim is to screen for novel treatments of calcineurin-related neural dysfunction. Overall, successful
completion of these aims will expand the methodologies for high-throughput analyses of complex behaviors,
provide a better basic understanding of calcineurin signaling in the brain, and contribute to the design of novel
treatments for calcineurin-related neural dysfunction. The project will benefit from the vibrant and collegial
research environment at Brown University. The principal investigator has a primary appointment in the
Department of Molecular Biology, Cell Biology and Biochemistry and is a faculty member in the Carney
Institute for Brain Science and the Center to Advance Predictive Biology. The department offers expertise in
developmental biology and cell signaling and the two centers provide a dynamic intellectual environment for
research in behavioral neuroscience and the analysis of signaling networks using high-content imaging
technologies.

Public health relevance
Project Narrative This project is focused on the development of novel imaging technologies for automated analyses of behavior. The imaging methodologies will be used to examine calcineurin-related behaviors in a high-throughput format and may lead to the identification of novel treatments for neural dysfunction.